Resolving single-cell analysis challenges via data-driven decision frameworks and novel statistical methods

Resolving single-cell analysis challenges via data-driven decision frameworks and novel statistical
methods
Abstract:
Despite the power of single-cell RNA-seq, the data presents a multitude of analytical challenges and
researchers continue to struggle with data analysis. The long-term goals of this research program are to
develop robust, efficient, and scalable statistical methods and tools that enable all scientists to obtain accurate
biological inferences. Specifically, we propose to develop interactive data-driven decision-frameworks to guide
researchers through analyses and make informed analytical decisions. We also propose developing methods
that retain interpretability while accommodating complex experimental designs. All of our approaches will be
developed as highly accessible statistical software with interactive visualization and analysis modules available
via webservers. Our proposed methods will result in richer analyses and biological insights, as well as,
improved reproducibility and reliability of scientific results.

Public health relevance
Project Narrative: Single-cell RNA-seq technologies have transformed the field of genomics and experiments are becoming widely used across both basic science and disease research. Yet, statistical methods and tools for analysis are exceedingly complex for non-experts and not adapted for more complex experimental designs. The proposed research programs will remove analytical barriers to analyzing scRNA-seq data and enable researchers to obtain deeper insights into their data by optimizing and streamlining their analyses without compromising on quality.